Collaborative Opportunities

COLLABORATIVE OPPORTUNITIES: ABSTRACT
The development of Regenerative Rehabilitation approaches to optimize tissue regeneration and repair
has the potential to enhance the efficacy of rehabilitation interventions for a host of injuries and diseases. To
accelerate scientific progress in this emerging field and to minimize disciplinary barriers, AR3T 2.0 has
assembled a diverse and multi-institutional network of laboratories that are conducting state-of-the-art research
in the domains of stem cell biology, regeneration, and regenerative medicine therapeutics. This network—21
laboratories strong—offers a broad range of consultative services intended to enrich the research capacity of the
medical rehabilitation research community across two core areas: Mechano- and Electro-Transductive Methods
and Pre-clinical Models of Rehabilitation. Collaborative projects between external investigators and AR3T 2.0
faculty members are incentivized through an aggressive national marketing campaign to highlight services
offered by the cores. To encourage broad utilization of core resources, our services are offered gratis to external
investigators, while compensating non-key personnel for time spent consulting with external investigators.
As a means to further support external junior investigators with an interest in pursuing Regenerative
Rehabilitation research, we recently inaugurated a Junior Scholars Development Program. This program
provides investigators with structured mentorship over a period of six months. The scholar is matched with an
AR3T 2.0 investigator with expertise is the desired area of research training. Together, the mentor and scholar
develop a personalized mentorship and research plan over the support period. When deemed appropriate by the
mentor and scholar, AR3T 2.0 also provides travel and stipend support for the scholar to complete a short-term
visit in the laboratory of the mentor. The purpose of these short-term stays is to provide hands-on technical
training as well as an opportunity for in-person interactions with the mentor.
We anticipate that successful completion of our aims to will continue to catalyze novel and promising
lines of collaborative investigations, as evidenced by manuscripts and grant submissions. More broadly, we
expect that these initiatives will help to propel the expansion of a generation of scientists committed to
Regenerative Rehabilitation research careers.